Neuroimaging and gut microbiome markers of development in HIV-exposed uninfected infants

Project Summary
Highly successful prevention of mother-to-child transmission (PMTCT) programs have reduced the
number of infants acquiring HIV from their mothers. In 2013 there were 1.3 million women living with HIV who
gave birth to 199,000 HIV-infected and approximately 1 million HIV-exposed, uninfected (HEU) infants. In
South Africa, where a 30% infection rate is reported among pregnant women at antenatal clinics, the HIV
epidemic continues to be a significant public health burden on women and children. Maternal HIV infection may
disrupt normal development of the infant gut microbiome, affecting the development of the immune system and
contributing to the higher morbidity and mortality of HEU infants. In addition, since microbiota influence
communication between the gut and the brain, changes in the infant gut microbiota related to maternal HIV
infection may help to explain the delayed neurodevelopment sometimes observed in HEU infants.
This proposal builds on the infrastructure and data of a recently funded study designed to measure the
effects of in utero and perinatal exposure to ART and HIV on the developing infant brain. The existing study
follows 210 infants, 140 HEU and 70 HU. At 38 to 41 weeks gestational age (GA), the infants will undergo
neuroimaging, including structural imaging for brain morphometry, diffusion for brain connectivity, and
spectroscopy for brain metabolism, and neurodevelopmental assessments at 9 and 19 months of age.
This proposal seeks to expand the current study, adding an additional neuroimaging time point (at 12
months), infant gut and maternal breast milk microbiome measures and breast milk oligosaccharide
composition. We will acquire infant gut microbiome samples at 5-7 days, 3 and 12 months. In addition, breast
milk samples will be acquired at 5-7 days and 3 months for microbiome analysis, and human milk
oligosaccharides (HMO) composition analysis at the first two time points. We hypothesize that abnormalities
identified in neuroimaging measures in HEU infants will be related to reduced gut microbiome diversity. The
goals of this study are to describe the maturation of the infant brain and gut microbiome composition, and to
examine the relationship between maternal breast milk HMO and microbiome composition, gut microbiome
diversity and neuroimaging measures. We seek to identify differences related to maternal HIV-infection that will
provide insight into increased risks of HEU infants and reveal potential areas for targeted intervention to
improve health and neurodevelopmental outcomes.
This project extends the existing collaboration between Drs van der Kouwe (Massachusetts General
Hospital), Meintjes (University of Cape Town (UCT)) and Laughton (Stellenbosch University), to include Dr.
Lars Bode from University of San Diego who is an expert in HMO composition, as well as three UCT-based
early stage investigators, Drs Holmes, Kaba and Robertson. The study aims to expand and strengthen local
capacity and interdisciplinary collaboration focused on locally relevant health problems.

Public health relevance
Project Narrative Prevention of mother-to-child transmission (PMTCT) programs have very successfully reduced infant HIV infection by their mothers, leading to an increasing population of HIV-exposed, uninfected (HEU) infants. Despite being uninfected, these children experience increased illness, risk of neurodevelopmental delay, and mortality, compared to their unexposed peers. In this project we will investigate the relationship between maternal HIV infection, breast milk composition, the developing infant gut microbiome, and the developing infant brain. We seek to identify differences related to maternal HIV-infection that will provide insight into increased risks of HEU infants and reveal potential areas for targeted intervention to improve health and neurodevelopmental outcomes.